A predictive model of left ventricle remodeling in the presence of injected polymer

PROJECT SUMMARY/ABSTRACT
In the weeks following myocardial infarction, damaged tissue undergoes a structural change, where myocytes
are broken down and removed, and collagenous tissue is restructured. This structural change impairs the tissue's
ability to resist internal pressures and if left untreated can lead to aneurysmal growth, ischemic mitral regurgi-
tation, and ultimately heart failure. Polymer injection therapy has been clinically shown to reduce post-infarct
left-ventricle cardiac wall remodeling, but the development of this treatment thus far has been largely experimen-
tal. Optimal therapy parameters, both for generic treatment and for individual patients are currently unknown.
Our objective for this proposal is to develop an experimentally guided computational model of left ventricle
remodeling that incorporates heart-speciﬁc imaging data, which will enable us to systematically optimize the
polymer injection therapy by examining the impact of treatment parameters such as injection volume, site density,
and polymer stiffness. This heart-speciﬁc imaging data will allow us to determine the effect of individual infarct
geometry and myocardium microstructure, and to tailor treatment to individual cases. We also seek to use this
image data to validate the long term predictions of this model, demonstrating that it can predict the remodeling
that occurs, and the impact of different polymer injection conﬁgurations. Therefore, it will serve to preemptively
consider multiple treatment options so clinicians can choose the best course of action for individual patients.
The objectives of this proposal are summarized in the three following speciﬁc aims:
SA1. Model post-infarct tissue remodeling matching established ovine MI model progression
SA2. Validate in a heart-speciﬁc pipeline at the tissue and organ levels
SA3. Utilize the previously generated model to optimize polymer injection treatment protocol

Public health relevance
PROJECT NARRATIVE A phenomenological model of post-infarct myocardial remodeling will be developed examining the impacts of polymer injection therapy on left ventricle wall structure. We will incorporate heart-speciﬁc image data both to tai- lor predictions and treatment to individual hearts, and to validate tissue and organ-level predictions. We envision that this model will in the future be used clinically to guide patient-speciﬁc polymer injection therapy.